Integrase Inhibitors during pregnancy and Neurodevelopmental Outcomes: Underlying Mechanism and Therapeutic Intervention

Project Summary
Background: Dolutegravir (DTG) is a first-line antiretroviral drug used in combination therapy for the treatment
of human immunodeficiency virus type-1 (HIV-1) infection. Due to the roll out of generic DTG-based regimen, its
inclusion in national treatment guidelines and rising pretreatment resistance to non-nucleoside reverse
transcriptase inhibitors (NNRTIs) in resource limited countries, in just 5 years, 15 million HIV-1 infected people
will be treated with DTG. This includes women of child-bearing age, who remain a significant infected population
(UNAIDS data, 2021). However, during recent years, growing data from clinical and pre-clinical studies have
suggested that DTG is associated with developmental neurologic abnormalities. Thus, concerns emerged for
the usage of DTG-based regimens in pregnant women or those of child-bearing age. Knowledge gap:
Underlying mechanism for DTG-associated developmental neurotoxicity (prenatal and postnatal), particularly in
babies born without structural, brain or spinal cord, malformations, remains unknown. Moreover, therapeutic
measures to enhance the DTG use for safer medication during pregnancy are infancy. Our preliminary data:
DTG was found to be a broad-spectrum inhibitor of MMPs. The drug was found to bind Zn++ at the catalytic
domain, leading to inhibition of MMPs activities. Moreover, studies in pregnant mice showed that DTG can cross
the placental barrier, accumulate in the fetal CNS and inhibit MMPs activity during the critical period of brain
development. Further postnatal evaluation of brain health in mice pups following in utero DTG exposures
identified neuroinflammation, neuronal damage and behavioral deficits. These data demonstrated an association
between DTG dysregulation of MMPs activities during gestation and consequent neurotoxicity. Hypothesis:
We posit that DTG inhibition of MMPs activities impairs pre- and post-natal neurodevelopment and offered long-
acting approaches will serve to improve drug’s therapeutic benefits during pregnancy. Research Strategy: (1)
Determine longitudinal dose-dependent effect of DTG on MMPs activity and/or expression in brain of embryos
and early age postnatal pups and identify impact of such inhibitions in MMPs activity on neuronal development.
(2) Investigate postnatal neurobehavioral outcomes that occurs across mouse development from adolescence
to young age following gestational DTG exposure. (3) Utilize long-acting poloxamer-based DTG
nanoformulations to provide potential delivery means to attenuate drug-associated neurotoxicity. (4) Establish
scientific exchange with clinical study to establish clinical relevance. Outcome: Successful outcome of the
proposal will significantly advance the basic and clinical research fields in understanding the theory of DTG
inhibition of MMPs activities as the underlying mechanism for DTG-associated developmental neurotoxicity,
impaired neurobehavioral outcomes, and provide long-acting poloxamer-encapsulated DTG nanoformulations
as potential delivery means to improve the safety and therapeutic profile of DTG during pregnancy.

Public health relevance
Project Narrative Proposal seeks to evaluate DTG-linked impaired neurodevelopmental outcomes with underlying mechanisms, assess long-acting poloxamer-encapsulated DTG nanoformulations as potential delivery means to improve safety and therapeutic profile of DTG during pregnancy and establish scientific exchange with ongoing clinical study examining children exposed to DTG in utero in Botswana for validating findings through clinical relevance.